Prenatal exposure to maternal incarceration and infant and toddler health and development

PROJECT SUMMARY ABSTRACT
The U.S. has the highest women’s incarceration rate in the world, with significant racial and economic
disparities. Approximately 3-4% of women enter prison or jail pregnant. Those who give birth during
incarceration are usually separated from their newborns, who live with another caregiver during the mother’s
incarceration. Although few studies have examined prenatal exposure to maternal incarceration in relation to
child health and development, emerging research suggests less optimal birth outcomes. Prenatal exposure to
incarceration is hypothesized to be detrimental to child development through several pathways including a)
antecedents of incarceration, including maternal substance abuse and chronic mental health conditions, b)
prison or jail conditions that are suboptimal for maternal and fetal health, c) characteristics of postnatal non-
maternal caregiving environments, and d) insecure attachment relationships due to unstable caregiving.
Preliminary data show that caregivers of children exposed prenatally to maternal incarceration frequently report
poverty, food insecurity, and mental and physical health issues. In addition, caregiving relationships are often
unstable over time, with one-third of infants experiencing a change in caregiving in the first year of life. The
proposed research analyzes data from the Birth Beyond Bars Study, a mixed-methods longitudinal study of
infants exposed prenatally to maternal incarceration. Mixed methods analyses will assess mothers’
retrospective reports of environmental experiences both before (e.g. prenatal substance exposure and
maternal mental health) and during incarceration that may threaten fetal development. Qualitative data will be
analyzed to characterize the mother-caregiver relationship and links to caregiver instability and mother-child
reunification. Analysis of quantitative data will examine predictors of children’s cognitive and social emotional
development. Training objectives include a focus on early childhood development and developmental
assessment, advanced qualitative data analysis, quantitative analysis of family data, and translation of
research for policy and practice.

Public health relevance
PROJECT NARRATIVE Children of mothers who were pregnant or gave birth to them while in prison or jail are at risk of poor development. Little is known about how these children develop over time and what might help or harm their development. This research will follow children whose mothers were pregnant or gave birth to them while in prison or jail for the first two years of children’s lives to understand how a mother’s incarceration during pregnancy might lead to poor child development.